Targeted Treatment of Obstructive Sleep Apnea with Dronabinol: Proof of Concept and Phase II Clinical Trial

Obstructive sleep apnea (OSA) is highly prevalent in Veterans, a population at high risk for
neuropsychiatric and cardiovascular sequelae of OSA. Continuous positive airway pressure and other
device-based or surgical treatments are limited by low adherence or are invasive. There is an urgent
unmet clinical need for effective medications to treat OSA. We have previously shown that six weeks of
Dronabinol, an FDA approved non-selective cannabimimetic medication, improves OSA compared to
placebo. While the overall effect was modest, some participants had a significant reduction in OSA
severity indicated by the apnea hypopnea index (AHI). This proposal aims to develop a prediction model
for AHI reduction after Dronabinol treatment, based on the participant’s polysomnographic and clinical
characteristics, in a proof-of-concept study (POC). In a subsequent phase II randomized controlled trial
(RCT), we will use the POC prediction model to randomize participants likely to respond to Dronabinol.
Alternatively, suppose the POC does not provide a robust prediction model. In that case, we will
randomize Veterans with moderate to severe OSA to determine the efficacy of twelve weeks of
Dronabinol treatment. We will also use the RCT data to develop a prediction model for a future phase III
RCT. Veterans will be enrolled at Jesse Brown VA Medical Center for the POC and RCT. We propose the
following specific aims:
Aim 1. To develop a prediction model for a reduction in AHI after 2-week Dronabinol treatment vs.
pretreatment AHI. The POC study will enroll Veterans with OSA (N=45, AHI 15-50/hour). Participant
clinical and polysomnographic characteristics from the POC data, or POC plus our preliminary study, will
be used to develop the prediction model. A predictive score threshold satisfied by ≥30% of participants
and with ≥80% positive predictive value to reduce AHI ≥10/hour will be determined.
Aim 2. To determine the efficacy of 12-week Dronabinol treatment in reducing AHI compared to
placebo (N=72). The enrollment criteria for the RCT will be like the POC study. If a robust prediction
model is achieved in Aim 1, participants achieving the predictive score threshold will be randomized.
Alternatively, participants with moderate to severe OSA will be randomized to determine efficacy, and the
data will be used to generate a predictive model for a future phase III RCT.
Aim 3. To explore changes in sleep symptoms, sleep architecture by electroencephalography,
daytime alertness, and 24-hour blood pressure after twelve-week Dronabinol treatment in Veterans with
moderate to severe OSA.
The clinical characteristics included in the prediction model will be demographics, symptoms,
comorbidity, pretreatment AHI, and Dronabinol blood levels. The polysomnographic characteristics
considered in the model will include quantitative pathophysiologic traits (endotypes: upper airway
collapsibility and compensation, loop-gain, and arousal threshold), respiratory, oximetry, and sleep
architecture metrics. The proposal includes a multidisciplinary team of collaborators with expertise in OSA
neuroscience (Carley, DW), computational measurement of OSA endotypes via polysomnography
(Mateika, JH), and advanced statistical modeling (Basu, S). The proposal leverages the research and
clinical resources at the University of Illinois at Chicago and Jesse Brown VAMC, which serves a large
pool of Veterans with OSA. The strengths of this study are: 1. Innovation: the potential to develop a
novel targeted pharmacologic management strategy for OSA, 2. Clinical applicability: using patient
characterization tools that are employable in clinical practice, and 3. Scientific rigor: a 12-week placebo
controlled RCT to test the effectiveness of Dronabinol treatment of OSA.

Public health relevance
Obstructive sleep apnea (OSA) is a significant health problem in U.S. Veterans and, if left untreated, can lead to neurocognitive dysfunction, cardiovascular disease, and death. Many Veterans with OSA remain untreated due to the inability to use continuous positive airway pressure or other device-based treatments. Surgical treatments are invasive and have limited efficacy. There is no approved pharmacologic treatment for OSA. We will conduct a proof-of- concept (POC) study using Dronabinol, an FDA-approved medication, to treat OSA. We will develop a model to predict a reduction in apnea hypopnea index with Dronabinol using the POC or POC plus our preliminary data. Next, we will conduct a 12-week placebo-controlled randomized clinical trial in Veterans with OSA to determine the efficacy of Dronabinol treatment. This project will lead to the development of a novel targeted pharmacologic treatment for OSA.